PPAR-gamma regulation of micro RNA metabolism in colon cancer

[unreadable] DESCRIPTION (provided by applicant): [unreadable] [unreadable] Peroxisome proliferator-activated receptor-gamma (PPARγ) is a potent suppressor of early stage colon carcinogenesis, and therefore a particularly attractive target for colon cancer chemoprevention. A number of studies have shown that activation of PPARγ in colon cancer cells inhibits proliferation and induces differentiation, suggesting that the tumor-suppressive effects of PPARγ are due to the ability to revert the transformation of early stage colon cancer cells. However, the mechanism that accounts for this process is unknown. We have recently completed a genomic profile of a battery of PPARγ sensitive and resistant human colon cancer cell lines. Our data reveal that reversion of the transformed phenotype is associated with inhibition of micro RNA (miR) metabolism. Specifically, PPARγ inhibits expression of Dicer1, which catalyzes the rate limiting step in conversion of inactive 75nt pre-miRs to active 21-23nt miRs. Downregulation of Dicer1 by PPARγ is associated with inhibition of maturation of a known oncogenic micro RNA, mir21. Recent data indicate that maintenance of the transformed phenotype may depend upon expression of colon cancer specific miRs (so-called oncomirs). Our observation that PPARγ inhibits Dicer1 expression suggests that the tumor suppressive effects of PPARγ may result from inhibition of oncomir-dependent processes that are required for maintenance of the transformed phenotype. To test this hypothesis, we will determine if knockdown of Dicer1 inhibits transformation in early stage colon cancer cells. We determine if overexpression of Dicer1 blocks the tumor suppressive effects of PPARγ, and we will test the hypothesis that some subset of PPARγ target genes are regulated secondary to repression of Dicer1 and inhibition of miR metabolism. Elucidation of this novel mechanism will provide fundamental new insight into our understanding of how PPARγ suppresses tumor formation, how miR metabolism is regulated in the colon, and how specific oncomirs contribute to transformation of colonic epithelial cells. Furthermore, we will identify a cohort of PPARγ/Dicer1 target mRNAs and miRs that may be essential for maintenance of the transformed state and therefore potential new targets for colon cancer chemoprevention. [unreadable] [unreadable] [unreadable]